Scalable and quantitative chromatin profiling from formalin-fixed paraffin-embedded samples

PROJECT SUMMARY
The development of tools to map the location of histone post-translational modifications (PTMs) genome-
wide has ushered in a new era of epigenetic research, placing histone PTMs and associated mechanisms in the
spotlight as novel biomarkers and therapeutic targets. Despite this progress, leveraging epigenomics for clinical
research has been hindered by a lack of high-performance genomic mapping assays that are compatible with
formalin-fixed paraffin-embedded (FFPE) tissue, due to DNA damage that is incurred during the FFPE process.
Indeed, existing FFPE sample-compatible genomic mapping assays are either low-throughput and insensitive
(requiring large sample inputs), or do not resolve specific chromatin features (e.g., promoters, enhancers, etc.).
Therefore, next-generation chromatin profiling assays that are able to resolve specific chromatin features using
banked FFPE samples are key to unlock access to the massive collection of banked clinical samples and enable
novel biomarker discovery / validation for disease-relevant histone PTM targets. To meet this need, EpiCypher
is developing CUTANA-FFPETM, a first-in-class low input genomic mapping solution for the study of FFPE clinical
samples. This technology is inspired by EpiCypher’s commercial CUTANA® CUT&Tag (Cleavage Under Targets
& Tagmentation) assays, and leverages an innovative in vitro transcription-based workflow to mitigate the
limitations imposed by FFPE sample processing-induced DNA damage. The goal of this Phase I study is to
demonstrate the ability of CUTANA-FFPE assays to reliably map histone PTMs in FFPE tissue samples. In Aim
1, we will develop the CUTANA-FFPE workflow to map histone PTMs in fixed cultured cells. Then, in Aim 2, we
will employ CUTANA-FFPE assays in clinical FFPE tissue samples and benchmark our results with genomic
maps derived from donor-matched fresh frozen tissue. This study will demonstrate feasibility for CUTANA-FFPE
to become a powerful new tool to perform high-value epigenomic research in previously inaccessible banked
clinical samples. This technology will be of broad interest to basic researchers and drug developers, unlocking
the full potential of epigenomics for clinical applications. In Phase II, we will develop robust CUTANA-FFPE kits
and automated assay protocols that are optimized for FFPE tissue using ultra-low sample inputs, which will be
key for commercializing CUTANA-FFPE to enable epigenomic studies of FFPE clinical samples.

Public health relevance
PROJECT NARRATIVE The development of tools to map the location of histone post-translational modifications (PTMs) genome- wide has ushered in a new era of epigenetic research, placing histone PTMs and associated mechanisms in the spotlight as novel biomarkers and therapeutic targets. Despite this, epigenetic studies of the millions of banked formalin-fixed paraffin-embedded (FFPE) clinical samples have been limited by the lack of high-quality assays compatible with these samples. To meet this need, EpiCypher is developing a novel FFPE sample-compatible genomic mapping assay to unlock access to the wealth of epigenetic information held in these samples and accelerate clinical research into histone PTMs as biomarkers and therapeutic targets.